Functional and Structural Correlates of Cognitive Dysfunction following TBI

Summary:
Although cognitive dysfunction is a frequent and debilitating symptom of traumatic brain injury (TBI), there are
currently no effective treatments available for this often persistent deficit. The neurophysiological basis for these
symptoms are unclear, as are the relative contributions of focal/diffuse pathologies in moderate/severe TBI. We
have developed and characterized two large animal (pig) models of focal brain injury with a diffuse component.
New advances in high-density electrophysiology are finally able to reveal how neuronal coding of memory is
altered by TBI, however it is unknown how this process is differentially affected in biomechanically accurate
translational animal models of focal/diffuse brain injury. Without a mechanistic understanding of how coding that
underlies cognition and memory is disrupted post injury, rational design of neuromodulatory and other therapies
remains challenging. Therefore, a critical need exists to determine the underlying mechanisms of the disruption
of memory encoding in cognitive networks TBI, and whether and how theta neuromodulation can restore function
in these models. In additional, the structural basis for these changes must be identified using advanced imaging
techniques validated by neuropathology. The long-term goal of this research is to elucidate the underlying
mechanisms whereby TBI leads to the disruption of memory and recall in limbic networks, and to develop novel
treatment strategies to improve memory and cognitive function. The overall objective of the current application
is to determine how the coding of memory in the hippocampus and associated circuitry is disrupted following TBI
in a gyrencephalic brain, the structural basis for this dysfunction, and whether and how theta neuromodulation
restores function. Our central hypothesis is that focal TBI disrupts communication within the extended
hippocampal network via axonal injury, disrupting oscillatory interactions required for encoding and recall of
memory in networks of synchronized neuronal ensembles. Furthermore, fronto-parietal CCI (CCI-FP) will disrupt
specific pathways between structures while leaving local circuitry intact, leading to loss of entrainment to HC
oscillations in PFC, whereas occipito-temporal (CCI-OT) will have direct effects on HC circuitry that propogate
to PFC. We will therefore first determine whether TBI affects phase amplitude coupling, phase precession, theta
sequences and replay in area CA1 of the hippocampus during tasks designed for these measures. In addition,
we will determine the mechanism of learning and memory dysfunction following TBI by examining neuronal
ensemble activity across HC-PFC, quantifying ripple features and replay, and correlating these measures with
complex behavioral function relying on these networks. We will then examine whether and how neuromodulation
restores spatial/working memory in pigs via simultaneous fimbria-fornix (FF) stimulation and high-density laminar
hippocampal/mPFC recordings during behavior. Advanced neuroimaging, both in vivo and ex vivo, will be
validated by neuropathology, and correlated with the behavioral and electrophysiological measures.
Accomplishment of these goals will provide the first detailed analysis of disrupted neuronal coding and oscillatory
interactions between brain regions during memory tasks in gyrencephalic TBI models. These experiments will
also identify the effects of neuromodulation on these networks and their functional restoration, leading to crucial
mechanisms that can be translated in the future to clinical treatments for this persistent sequelae of TBI in our
Veterans.

Public health relevance
Narrative The proposed research is highly relevant to Veterans health, because although cognitive dysfunction is a frequent and persistent symptom of traumatic brain injury (TBI), there are currently no effective treatments available for this persistent deficit. In addition, the neurophysiological basis of these deficits remains unknown, making rational treatment design difficult. This project will therefore define for the first time the underlying functional basis for cognitive dysfunction in biomechanically relevant TBI models with complex behavioral metrics. In addition, advanced neuroimaging that is clinically relevant will be evaluated as a tool for identifying white matter (axonal) disruption relevant to these functional and behavioral deficits. The project is relevant to the VA BLR&D mission because knowledge of why TBI induced cognitive disorders persist, and how neuromodulation alleviates them in relevant animal TBI models of different types of injury, will allow for clinical treatment development that will reduce the burden of these deficits in our Veterans.